Purchase of a Real-Time Polymerase Chain Reaction System to Maintain and Expand VetLIRN Capacity

There is a public health need for veterinary laboratories to have significant capacity to test
animal diagnostic specimens and food/feed samples rapidly and accurately for the presence of
important pathogens including Salmonella, Campylobacter, Listeria and SARS-CoV-2. The FDA
Veterinary Laboratory Investigation and Response Network (Vet-LIRN) is a group of veterinary
laboratories tasked with protecting the health of humans by being able to rapidly and robustly
respond to outbreaks associated with animals and animal products. This equipment-only grant
requests support for the purchase of a QuantStudio 3 real-time polymerase chain reaction
(PCR) system to maintain the capacity of a Vet-LIRN member laboratory (Ryan Small Animal
Hospital Clinical Microbiology Laboratory at the University of Pennsylvania) to perform testing
for diagnostic, monitoring and surveillance purposes. It will also allow the laboratory to more
fully engage with proficiency testing and interlaboratory comparison exercises developed by
Vet-LIRN.

Public health relevance
Molecular detection of pathogens is at the core of modern surveillance and outbreak investigation and response and molecular techniques have been established for use by the FDA’s Veterinary Laboratory Investigation and Response Network (FDA VetLIRN). This equipment-only grant is to support the purchase of the QuantStudio 3 real-time PCR system for a VetLIRN member laboratory (Ryan Veterinary Hospital Clinical Microbiology Laboratory at the University of Pennsylvania). Purchase of this equipment will maintain and expand our capacity to perform testing for organisms highly relevant to VetLIRN’s overall mission.